P30-Core Grant for Vision Research Core B

Functional Genomics & Proteomics (FG&P) Core
ABSTRACT
The Functional Genomics and Proteomics (FG&P) Core supports research that increases our understanding of
how biological function (e.g., vision) arises from the information encoded in an organism's genome. The Core
provides support for the design, execution, and analysis of molecular, biochemical, proteomic, and phenotypic
experiments in six sections: DNA/RNA services, protein/small molecule analysis, cell culture, ocular/vision
structural and functional analysis, rodent ocular microsurgery, and mouse colony services. This support comes
largely via the expertise and services of Core personnel, the availability of equipment, supplies, and other
Core-dedicated resources, and their training of individuals from laboratories of the Atlanta Vision Research
Community (AVRC; Emory University, Georgia Tech, Morehouse School of Medicine, Atlanta VA Healthcare
System, and Georgia State University). The FG&P Core provides this support for AVRC investigators who are
NEI R01-funded but who cannot justify such services or equipment independently in a single R01-funded
project or who are not experts in FG&P techniques. By removing “barriers of entry” that are caused by lack of
experience with or lack of access to specialized approaches and equipment, the FG&P Core helps these
investigators increase the impact of their research. This support also enhances collaborations across the
AVRC by providing uniformity in methodologies supported by the above sections and equal access across
institutions. The goal of Drs. Boatright and Pardue is to provide Core use at all times and at all locations to
every AVRC investigator. Under their leadership, no AVRC investigator lacks Core support.

Public health relevance
The Functional Genomics and Proteomics (FG&P) Core supports research that increases our understanding of how biological function (e.g., vision) arises from the information encoded in an organism's genome. The Core provides expertise, personnel, training, and equipment for the design, execution, and analysis of molecular, biochemical, proteomic, and vision function and structure experiments. This support is for AVRC investigators who are NEI R01-funded but who cannot justify such services or equipment independently in a single R01- funded project or who are not experts in FG&P techniques. By removing these "barriers of entry," the FG&P Core helps these investigators increase the impact of their research.